Neurocomputational mechanisms of proactive social behavior deficits in autism spectrum disorder

Project Summary
Social interaction deficits are at the crux of autism spectrum disorder (ASD) and contribute to significant
functional impairment, including poorer relationship quality and low employment rates in individuals with ASD.
Despite an enormous amount of research dollars invested and thousands of research papers published on the
topic, we remain far from understanding the basic neural computations underlying social processes in ASD. In
the current proposal, we posit that this information gap is due in part to the rarity with which computational model-
based analyses are used in ASD neuroimaging research. Additionally, most studies use passive paradigms (e.g.
face perception) rather than examining brain functioning while participants engage in ecologically-relevant,
interactive social tasks more akin to the type of interactions with which people with ASD struggle in their daily
lives. This proposal takes an innovative computational psychiatry approach to understanding aberrant neural
computations of social interactions in ASD, using high-resolution (7T) functional magnetic resonance imaging
(fMRI) and virtual reality-like tasks that test individuals’ abilities to proactively and dynamically engage in
simulated social interactions. In particular, we focus on the ability of individuals with ASD to: 1) discriminate and
track levels of closeness and power when navigating social interactions in a choose-your-own-adventure style
interactive paradigm, and 2) understand and adapt to social norms and exert control over social others in the
context of a proactive social exchange paradigm. We use novel computational models to examine the neural
computations and connectivity underlying proactive social behavior, focusing on brain regions (e.g.,
hippocampus) that have been understudied in the context of social deficits in ASD. Finally, we use machine
learning approaches to explore ASD heterogeneity along dimensions of dynamic and proactive social
interactions and apply these indices to make clinically-meaningful predictions. We hypothesize that: 1)
hippocampal tracking of social space will be less robust in ASD as compared to neurotypical controls and will
correlate with social symptoms; 2) ASD individuals will show slower norm adaptation rate, greater aversion to
norm violation, and reduced social controllability, accompanied by reduced neural encoding of social values in
anterior insula and ventral striatum; and 3) these parameters will help identify subtypes of ASD and predict ASD-
relevant outcomes (e.g. social skills, adaptive social functioning, quality of life). We expect that findings from this
project will break new ground and fill critical knowledge gaps regarding the neurobiology of ASD. In particular,
we expect our findings will greatly enhance understanding of the neural and computational mechanisms
underlying deficits in proactive social behavior in ASD and will allow us to identify distinct, neurobiologically-
driven clusters. In so doing, the results of this project could offer new tools by which to subtype the ASD
phenotype and provide novel insights into treatment targets.

Public health relevance
Project Narrative Despite social deficits being core features of autism spectrum disorder (ASD) and contributing to relationship difficulties and low employment rates, their neurobiological underpinnings are poorly understood. The goal of this study is to gain new knowledge about the brain mechanisms underlying social deficits in autism using computational modeling, novel brain imaging tools, and interactive experimental tasks that simulate dynamic social interactions. In contributing to our understanding of the brain basis of ASD, this study may unveil new directions for intervention.